Exploring cyclic di-nucleotide signaling across the tree of life

Project Summary is not required for this equipment supplement.

Public health relevance
Project Narrative. This Administrative Supplement request funds for the purchase of a AKTA Pure 25 M1 FPLC protein purification system through Notice NOT-GM-21-030 to support the parent grant R35 GM139537-01, “Exploring cyclic di-nucleotide signaling across the tree of life”. The FPLC system will increase our efficiency and success in purifying numerous proteins such as transcription factors and cyclic di-nucleotide synthesis and degradation enzymes.